Switching and Candida Pathogenesis-A Molecular Analysis

DESCRIPTION (Verbatim from Applicant's Abstract): Candida albicans switches spontaneously, reversibly and at high frequency between a limited number of general phenotypes distinguishable by colony morphology. Switching is highly pleiotropic, regulating a variety of phenotypic characteristics and involving the differential expression of phase-specific genes. Switching therefore, provides colonizing populations with spontaneous variants for rapid adaptation during commensalism and pathogenesis. Using the white-opaque phase transition in strain WO-1 as an experimental system, we have demonstrated that the histone deacetylase Hda1p functions as a suppressor of switching in the white-to-opaque direction, that the silent information regulatory Sir2p is not involved in the white-opaque transition, but functions as a suppressor of a second switching system analogous to that in strain 3153A, and that phase specific genes are regulated downstream of the switch event through phase-specific trans-acting factors. We now propose 1) to develop a more accurate model of the downstream regulatory circuitry involved in phase specific gene expression, 2) to elucidate the protein-DNA and protein-protein interactions involved in the regulation of select white and opaque phase genes, with emphasis on the role of the MADS box proteins in opaque phase expression of OP4, Rbf1p in white phase expression of WH11 and transcription of the phase regulated trans-acting factor EFG1, 3) to elucidate the roles of acetylation/deacetylation and gene silencing in switching, and 4) to assess the impact of the deletion of phase-specific regulatory molecules on pathogenesis in two animal models, one in which white phase cells are more pathogenic than opaque phase cells, and the other in which opaque phase cells are more pathogenic than white phase cells. The first three aims have been formulated so that they provide several independent starting points for a reverse genetic approach for elucidating switch loci and the switching mechanism.